Transcriptional Dynamics of Photoreceptor Gene Regulation.

Project Summary/Abstract
The homeodomain transcription factor Crx is expressed at the final mitosis of photoreceptor
precursors, is involved in epigenetic remodeling, binds to promoters to activate photoreceptor-
specific genes and silence other genes. In this proposal, we will investigate target search
dynamics in live photoreceptors – how it transits the complex nuclear environment to find
regulatory DNA target elements within the mass of non-specific DNA in chromatin. We will develop
quantitative single-particle tracking super-resolution imaging (sptPALM) to characterize Crx
dynamics in a new model. We have created a knock-in mouse line in which the coding region of
a next-generation photoswitchable fluorescent protein, mEos4b, was inserted into the Crx gene.
Since mEos4b is in the endogenous Crx locus, expression levels will be similar to native
concentrations throughout development. We will answer the following three fundamental
questions: 1) What mobility modes are employed by Crx in photoreceptor nuclei? 2) How long is
Crx bound to chromatin? 3) Are Crx dynamics different in rods, cones, photoreceptor precursors,
or bipolar cells? Our model will give us unprecedented access to nuclear dynamics of Crx
throughout the lifespan of photoreceptors.

Public health relevance
Project Narrative This project will to develop new approaches to answer key questions about gene expression in the retina: How do transcription factors find their regulatory DNA target sequences within the mass of non-specific chromatin? How do retinal transcription factors transit the complex nuclear environment? We have developed a new model to study transcription factors in live photoreceptors and propose to employ innovative super-resolution microscopy to study the dynamics of retinal transcription factors using single particle tracking.